CLINICAL PREDICTOR OF TACHYCARDIA RESPONSE TO DRUGS

This study will be a retrospective analysis of all the patients that were brought to the electrophysiology laboratory for evaluation and who had inducible, monomorphic, sustained ventricular tachycardia. Their drug response will be assessed and the drug responsiveness will then be correlated to various clinical parameters.